Blood DNA Methylation Biomarkers of Alzheimer’s Disease and Postoperative Neurocognitive Disorder

Abstract
The most common complication to affect older adults after surgery is the development of a perioperative
neurocognitive disorder. Up to 30% of patients over 60 develop postoperative cognitive dysfunction (POCD),
also termed neurocognitive dysfunction (postoperative) (NCD), within 6 weeks after a surgical procedure.
POCD/NCD is characterized by impairment of memory, attention, learning, concentration and/or executive
function on psychometric testing. Patients with POCD/NCD may experience persistent cognitive dysfunction over
7 years after surgery, greater loss of independence, leaving the labor market, higher health care costs, and
increased morbidity and mortality. The etiology and pathogenesis of POCD/NCD are poorly understood. At
present, no biomarkers of susceptibility to POCD/NCD are available for use before surgery, or for guiding
diagnosis and management of POCD/NCD. Mild cognitive impairment and late onset Alzheimer's disease are
risk factors for cognitive decline after surgery suggesting overlapping pathophysiology. Recently, we reported
over 450 differentially methylated positions in DNA from blood samples that distinguish persons with Alzheimer's
disease from cognitively healthy persons matched for age and sex. Patterns of DNA methylation regulate gene
expression by coordinating the influence of environmental factors and genetic coding sequences. Accordingly,
in this application we will test whether blood samples acquired before surgery provide DNA methylation
biomarkers of Alzheimer's disease that distinguish patients who are at risk for POCD/NCD after surgery from
those who are not (Specific Aim 1). As well, we will test blood samples acquired 6 weeks after surgery for
biomarkers of Alzheimer's disease that are differentially methylated from baseline levels before surgery in
patients with and without POCD/NCD (Specific Aim 2). Our technical innovation is the use of the Illumina Infinium
MethylationEPIC BeadChip to classify DNA methylation status at over 850,000 candidate cytosine loci in
longitudinal blood samples from patients with and without POCD/NCD. These data will provide new predictors
of susceptibility to POCD/NCD for the diagnosis, prognosis, and care of patients with POCD/NCD. In turn,
differentially methylated positions at previously unknown loci and pathways will support a more complete
understanding of heritable and acquired mechanisms that underlie POCD/NCD with potential to identify novel
therapeutic targets.

Public health relevance
Project Narrative Older adults undergo 1/3 of the more than 40,000,000 surgeries and anesthetics delivered each year in the United States, and up to 30% experience a decline in memory, attention, learning, concentration and/or executive function 6-10 weeks thereafter termed postoperative cognitive dysfunction (POCD), also termed neurocognitive dysfunction (postoperative) (NCD). The proposed research has direct public health implications in view of the major impacts of POCD/NCD on cognitive and health trajectories related to Alzheimer's disease after surgery, and the lack of bedside tests for POCD/NCD screening and prevention. The present proposal carries immediate relevance to the NIH's and NIA's missions of fostering innovative research to improve health through new prognostic and diagnostic tools, and identification of novel therapeutic targets for POCD/NCD and Alzheimer's disease.